The role of peripheral cardiovascular signals in the interoceptive effects of alcohol

Abstract
Interoception is the process of sensing and integrating internal signals, which is critical for maintaining bodily
homeostasis. Interoceptive signals such as hunger, thirst, or arousal can thus impact behavior. Alcohol, as well
as all other drugs of abuse, produces distinct interoceptive effects (i.e., lightheadedness, dizziness, relaxation).
These interoceptive effects can vary dramatically by dose. Given the rich conditioning history one experiences
between alcohol drinking and the interoceptive effects associated with drinking, it is important to consider that
these effects could have the potential to influence drinking (signaling satiety or priming more drinking). While
advances have been made in our understanding of the CNS neural circuitry and molecular mechanisms that
modulate the expression of alcohol interoceptive effects, little is known regarding the role of peripheral cues to
these interoceptive effects. Afferent signals from the cardiovascular system are one of the major sources of
interoceptive information and as such perception of cardiac activity is a salient and central feature of
interoception. To this end the goal of this application is 1) to characterize the role of peripheral cardiovascular
information (heart rate and blood pressure) in the expression of the interoceptive effects of low and
moderate/high alcohol doses, and 2) the functional role of the nucleus of the solitary tract (NTS), a primary
brainstem target of visceral afferents in the integration of cardiovascular signals underlying alcohol interoceptive
sensitivity. One of the NTS efferent targets is the nucleus reuniens (Re), a basal midline thalamic nucleus that
has been relatively understudied in its role in interoception. In Aim 1, studies will assess cardiovascular signals
across alcohol interoceptive training and take a pharmacological approach to directly test the functional
involvement of peripheral cardiovascular signals to alcohol interoceptive effects. Studies in Aim 2 will assess the
functional role of the NTS and the NTSnucleus reuniens (Re) pathway in alcohol effects and as a critical
component of these cardiovascular signals. The results of the proposed studies will provide new insight into our
understanding of alcohol interoceptive effects and would be the first preclinical studies to characterize peripheral
cardiovascular signals in the interoceptive stimulus effects of alcohol. These findings will have broad relevance
for improving our understanding of interoceptive processing and the interplay between peripheral changes and
motivated behavior that is guided by alcohol interoceptive effects.

Public health relevance
Project Narrative Alcohol, as well as all other drugs of abuse, produce distinct interoceptive effects (i.e., high, dizziness, nausea) and it is important to consider that these effects have the potential to influence drinking (signal satiety or promote more drinking). Signals from the cardiovascular system are one of the major sources of interoceptive information and perception of cardiac activity is a salient and central feature of interoception. Therefore, the present project seeks to investigate the role of cardiovascular signals in the interoceptive effects of alcohol which will provide new insight into our understanding of peripheral contributions to alcohol interoceptive effects.